MODULATION OF THE RECOMBINANT P450S'ENZYME ACTIVITY

Expressed cytochromes P450 can be used as activation systems for promutagens and to screen natural compounds for isozyme specific inhibitors. In order to optimize the activities of cDNA-expressed mouse CYP1A1, mouse CYP1A2, human CYP1A2, and human CYP2B6, in Hep G2 and TK- cells, these P450s were co-expressed with human NADPH-oxidoreductase. In hepatoma cells, co-expression resulted in a greater affinity of the enzyme to its substrate or inhibitor. With embryoblast cells, co- expression resulted in an increase in specific activity of CYP1A enzymes without a change in their affinity values. The modulatory effects of several natural flavonoids were studied for their effects on cDNA- expressed mouse and human CYP1A isozymes. A comparison of the mouse and human CYP1A2s revealed a species specific difference in their responses to flavonoids. Structure-activity relationships showed the importance of hydroxyl groups in the 5- and 7-positions of the A ring of the flavone nucleus. The ortho-orientation of a hydroxyl group on the B ring was of importance too. In addition, the recombinant P450s were used to seek among natural and synthetic compounds for isozyme specific monooxygenase inhibitors.